Context-Specific Regulation of NFkB Signaling Dynamics in Primary Macrophages

PROJECT SUMMARY/ABSTRACT Macrophages are ubiquitous tissue-resident cells that are essential for tissue homeostasis and function. Macrophages coordinate the inflammatory response to pathogens, as well as, coordinate tissue repair programs. The diverse and context-specific functions of macrophages are represented in their epigenome. Misregulation of macrophage functions is implicated in autoimmune disorders. Understanding of how context- specific functions of macrophages are regulated by different cytokines is lacking. Elucidating how cytokines regulate macrophage function can inform novel immunotherapeutic approaches for targeting autoimmune diseases. The objective of this application is to examine how conditioning by cytokines, such as IFNγ and TNF, regulates macrophage inflammatory responses via NFκB signaling dynamics. NFκB signaling will be measured using time-lapse microscopy in primary macrophages from RelA-mVenus knockin reporter mouse. The epigenomes and transcriptomes of conditioned macrophages will be examined using Histone ChIP-seq, ATAC-seq, and RNA-seq. Specifically, the proposed studies will address how IFNγ and TNF regulate the temporal pattern of NFκB nuclear translocation. Preliminary data show that oscillatory NFκB translocations preserve the epigenomic landscape of macrophages, whereas non-oscillatory NFκB nuclear translocations disrupt the cell type-specific epigenomic landscape. Hence, control of NFκB dynamics by IFNγ and TNF conditioning may regulate cell-type specific gene expression in macrophages. In Aim 1, I examine how loss of tonic TNF abolishes NFκB oscillations and the consequences on the macrophage epigenome and transcriptome. In Aim 2, I examine how IFNγ-priming of macrophages abrogates NFκB oscillations and the consequences on the macrophage epigenome and transcriptome.

Public health relevance
PROJECT NARRATIVE Although TNF and IFNγ regulate the oscillatory dynamics of the inflammatory transcription factor, NFκB, in macrophages, the underlying mechanism and the significance on macrophage functions are not known. Here, I will examine how TNF and IFNγ regulate NFκB oscillations in macrophages and the consequences on the macrophage epigenome and transcriptome.